Dissecting Cell Type Specific Functions of CHD7 in Development of the Neocortex

PROJECT SUMMARY/ABSTRACT
The aim of this proposal is to determine how heterozygous mutation of the chromatin remodeler CHD7
(Chromodomain Helicase DNA-binding protein 7) disrupts development of the neocortex, leading to the
neurodevelopmental anomalies associated with CHARGE syndrome. CHARGE syndrome is characterized by
substantial behavioral and cognitive problems, including executive dysfunction and Autism Spectrum Disorder
(ASD). The proposed research team recently identified abnormalities in the neocortex of Chd7 heterozygous
mice, implicating CHD7 in key, temporally distinct developmental processes. Preliminary data suggest that
anterior-posterior (A-P) patterning of the neocortex is disrupted in these mice and that CHD7 directly regulates
the expression of a master regulator of A-P patterning, Nr2f1 (COUP-TF1). These mice also exhibit cortical
hypoplasia, implicating Chd7 in cortical growth. Furthermore, excitatory and inhibitory synapses onto deep layer
principal neurons of the prefrontal cortex (PFC) are affected by Chd7 haploinsufficiency. Both executive
dysfunction and ASD have been linked to PFC dysfunction. Thus, these findings provide the long-sought
opportunity to identify the mechanisms whereby CHD7 haploinsufficiency disrupts neocortical development.
Chd7 function is context-dependent; hence, a significant focus will be to define sex-, region- and cell-type-specific
functions and mechanisms. This project's specific aims are to 1) test the hypothesis that Chd7 haploinsufficiency
disrupts A-P patterning of the neocortex, 2) define the molecular and cellular functions of Chd7 in neural
stem/progenitor cells of the neocortex and subpallium and 3) test the hypothesis that Chd7 has cell-type-specific
functions in the development of synapses in the PFC. The team will use standard and innovative methods to
visualize and quantify the expression patterns and levels of markers of A-P patterning, and quantify region-, cell-
and sex-specific abnormalities in excitatory and inhibitory neurogenesis. Bulk and single cell next generation
sequencing approaches will be used to identify transcriptional and chromatin changes in different regions and
cell types of the Chd7-deficient developing neocortex in both sexes. The multi-institute team brings together
expertise in neurodevelopmental functions of CHD proteins (Basson), translational and modeling studies of
CHARGE syndrome (Martin), genomics of cortical development (Kwan), and synapse physiology (Andreae).
Together, this work will provide a comprehensive understanding of the impacts of CHD7 haploinsufficiency on
multiple processes in development of the neocortex and identify cell-type-specific functions for CHD7 in neural
progenitor differentiation and PFC circuit assembly. Successful completion of this work will generate the
knowledge and tools necessary to identify the neurodevelopmental mechanisms and circuits that underlie
specific behavioral and cognitive phenotypes associated with CHARGE syndrome and other related disorders.

Public health relevance
PROJECT NARRATIVE CHARGE syndrome is a developmental disorder characterized by substantial behavioral and cognitive problems, including executive dysfunction and Autism Spectrum Disorder (ASD) also prevalent in many other neurodevelopmental disorders. In this study, we seek to understand how mutation of the gene that causes CHARGE syndrome disrupts critical processes in development of the neocortex, including patterning, brain growth and synaptogenesis. In the longer term, this work will help us understand the causes of specific brain disorders and the critical cell types and processes to target for therapeutic benefit.